Exploring mechanical mechanisms of antibiotic resistance

Summary
Traditionally, studies of antibiotic resistance have focused on evolutionary and molecular
mechanisms of resistance. However, many of our best antibiotics target the bacterial cell envelope,
which is a mechanically robust, structural exoskeleton for the cell. Ultimately, these antibiotics cause
cell death by weakening the envelope enough to cause explosion of the cell by the large, hydrostatic
pressure within it. Despite the central mechanical importance of the cell envelope, we have little
understanding of which molecules and moieties within it are critical for its load-bearing capacity.
Addressing this question would transform our understanding of antibiotic resistance. A primary
reason for this gap in our knowledge is the formidable challenge of applying mechanical forces to
single bacterial cells while monitoring their physiology. The proposed research will address this
obstacle by applying innovative, highly precise, high-throughput microfluidics and microscopy-based
assays to measure the mechanical properties of two of the major cell envelope components in
bacteria, the outer membrane and the cell wall. These assays will be combined with molecular and
cell biological techniques, and biophysical theory, to explore an emerging paradigm within
microbiology: that bacteria control antibiotic resistance by adaptively tuning the mechanical properties
of their cell envelope. First, building on the recent landmark finding that the outer membrane confers
antibiotic resistance to bacteria because of its mechanical strength, the dependence of outer
membrane stiffness and mechanical antibiotic resistance on the fine-scale biochemical composition of
the outer membrane will be systematically measured. Next, the mechanism of outer membrane
vesiculation (a process underlying antibiotic resistance and pathogenesis) will be investigated by
combining a theoretical mechanical model of vesiculation with novel microscopy assays to quantify
vesiculation dynamics, while genetically tuning protein-protein interactions between the cell wall and
outer membrane. Finally, the scope of these studies will be extended to Gram-positive bacteria by
determining the dependence of antibiotic resistance on cell wall stiffness in these species, specifically
focusing on the mechanical contributions of teichoic acids to resistance. Together, these studies will
transform our understanding of bacterial pathogen survival and growth, and point to fresh strategies
to circumvent antibiotic resistance and treat bacterial infections.

Public health relevance
Narrative Many of our front-line, broad-spectrum antibiotics target the synthesis of the bacterial cell envelope and ultimately cause cell death via fracture of this structural exoskeleton. Therefore, determining the molecular basis for the mechanical properties of the cell envelope and, in turn, the mechanisms by which bacteria modify these properties to promote antibiotic resistance will provide brand new strategies to combat this crisis based on undermining the mechanical integrity of bacterial cells. Furthermore, the ability to manipulate the mechanical properties of the cell envelope will provide new tools with which to probe the mechanics of other important physiological processes important for pathogenesis, such rapid proliferation and adaptation to environmental fluctuations.